ACTG 225:A PHASE II STUDY OF SEROCONVERSION OF MEASLES VACCINATION IN

This is a phase II study comparing one dose versus two doses of measles vaccine in infants 6 months of age at entry who were born to HIV-infected mothers.